Therapeutic antibody for anorexia nervosa

Therapeutic antibody for anorexia nervosa
Abstract
Anorexia nervosa (AN) is a psychiatric condition characterized by changes in eating habits eventually leading to
weight loss of more than 15% and up to 85% in comparison to a healthy population. The natural course is
variable, and long-term mortality is one of the highest of any psychiatric disorder. Treatment relies on nutritional
and psychotherapy, and no specific drug treatment has been identified for AN. Growth differentiation factor 15
(GDF15) is well documented as a critical mediator of body weight loss, and high GDF15 levels are associated
with AN. Administration of GDF15 causes weight loss in mice, rats, and primates. We have identified a high-
affinity human monoclonal antibody that neutralizes GDF15 in animal models of tumor-associated cachexia.
During this Phase 1 project, we will demonstrate activity of this antibody in murine models of AN. Phase 2 studies
will advance preclinical testing, including pharmacokinetics and toxicology, in preparation for an IND. The
therapeutic antibody to be developed in this project will directly block a major cause of weight loss to improve
quality of life in AN patients.

Public health relevance
Narrative Anorexia nervosa is a severe eating disorder leading to poor quality of life, with one of the highest mortality rates of any psychiatric disorder. Treatment relies on nutritional modification and psychotherapy, and no specific drugs are approved for AN. We have identified a monoclonal antibody that targets a pathway involved in appetite and body weight homeostasis. During this study, we will evaluate this antibody in laboratory models of AN. With further development, this treatment has the potential to be the first efficacious targeted therapeutic for AN.